Administration Core

The Administrative Core will provide leadership, facilitate and coordinate the research efforts of the three main projects and the pilot project and Core B (the Animal and Behavior Core). Core A of this Multi-PI P01 is directed by Dr. McKenna, Dr. Bearer and Dr. McCarthy who will serve as Principal Investigators with the assistance of a part time administrative assistant. Dr. McKenna will serve as the Contact PI of this multi-PI Grant. Dr. Bearer will provide a clinical perspective and assist each PI in identifying research projects for Neonatology fellows and residents and assist with oversight for fellowship projects. Dr. McCarthy will provide advice and insight to all investigators from her in depth expertise in cerebellar development and function and assist with designing and establishing the interactive relational database that will facilitate active collaboration of all of the PIs and projects. Core A will organize biweekly meetings of the P01 PIs, the four Project PIs, Core Director and Co-Director, and biostatistician, (these individuals comprise the Oversight Committee) and monthly meetings of the oversight committee with all other participants on this P01 to discuss research findings and plan interactive research studies. Core A will also arrange quarterly meetings of the P01 PIs, Project PIs, Core B Director and Co-Director and biostatistician with the Internal Advisory committee to cover progress, direction and quality control. Core A will also facilitate the video conferences with members of the External Advisory Board and organize/coordinate any visits from members of the External Advisory Board. Critically, Core A will directly handle the Core A budget and oversee the budgets of Projects I-IV and Core B in collaboration with department business managers. A biostatistician in Core A will provide statistical support and advice regarding experimental design and data analysis for all of the Projects and Core B. Core A will work directly with Core B to maintain the intranet-based interactive calendar, message board, Drop Box site and customized Relational Database. Core A will provide oversight to the research training of pediatric residents and fellows. In addition, Core A will monitor cost effectiveness and quality control. As with any successful joint effort, the directorship of this MPI-P01 will provide checks and balances to sustain the highest scientific and administrative standards.